CTSA Predoctoral T32 at Johns Hopkins

Project Summary/Abstract
The mission of the Johns Hopkins University (JHU) Institute for Clinical and Translational Research (ICTR)
Predoctoral Clinical Research Training Program (T32) is to provide an integrated set of training opportunities
focused on the core principles of translational science. We will build on our success of training more than 150
predoctoral students to date by focusing the training experience on (1) specific skills for competency in research
(2) individual mentored project development and (3) community engagement. A core program goal is to advance
diversity among researchers in translational science. We have a track record of training scholars who are
underrepresented in medicine at a rate higher than the national average. We will continue to advance this goal,
including for trainees from disadvantaged backgrounds or with disabilities. Our history of successful recruitment
and selection of a diverse group of trainees from participating institutions allows us to build on our efforts to enroll
a wider range of trainees in diverse disciplines. We will use existing strategies to recruit trainees in medicine,
nursing, dentistry, and public health with diverse scientific interests and perspectives in translational science.
Our partnerships with MSU, a Historically Black University (HBU), and UMB will provide additional access to
diverse perspectives to help address health disparities. We (1) Teach core principles in clinical and translational
research, ensuring trainees have the knowledge and skills to succeed in their scientific pursuits and build an
identity as translational researchers; (2) Provide a supportive and collaborative culture for trainees; (3) Create a
community of clinical and translational science trainees, building networks and collaborations among trainees
(and mentors), driving innovation; and (4) Encourage the development of team science skills. Trainees will
recognize the importance of working collaboratively, an increasingly critical research skill. Our integrated
program offers a multidisciplinary mentoring team, didactic training, competency-based interactive workshops,
core ICTR resources, peer-support and resource-sharing designed to stimulate lifelong engagement in a clinical
and translational research career. The program offers trainees intensive and hand-on learning experiences that
prepare them to be exemplary clinical and translational scientists in any discipline, specialty or subspecialty. Our
heterogeneous pool of trainees will emerge equipped with the knowledge, skills, and abilities to advance
diagnostics, therapeutics, clinical interventions, and behavioral modifications to improve health and reduce
health disparities as they develop into independent researchers. We will perform continuous program evaluation
with multiple metrics. We evaluate the program itself (faculty, courses, seminars) and track enrollment, retention,
and diversity of trainees; and conduct course and mentoring evaluations. Like the consortium of CTSA academic
medical institutions across the country, we will report on trainee performance and satisfaction, and mentor
satisfaction. We will also measure, evaluate, and disseminate the impact of translational research from our
program. The JHU ICTR T32 will support 10 predoctoral trainees per year for a minimum of 12 months.

Public health relevance
Project Narrative The mission of the Johns Hopkins University (JHU) Institute for Clinical and Translational Research (ICTR) Predoctoral Clinical Research Training Program (T32) is to provide an integrated set of training opportunities focused on the core principles of translational science. Our partnerships with MSU, a Historically Black University (HBU), and UMB will provide additional access to diverse perspectives to help address health disparities. The program offers trainees intensive and hand-on learning experiences that prepare them to be exemplary clinical and translational scientists in any discipline, specialty or subspecialty.